A substrate for durable gut-brain signaling

PROJECT SUMMARY/ABSTRACT
Humans prefer foods to which they have been exposed early in life. This has significant implications for obesity
as early exposure to foods with excess sugar can lead to unhealthy food choices later in life. However, the
mechanism by which early food exposure leads to long-term changes in food preferences is unclear. Recently,
it has been established that specialized sensory cells in the gut epithelium called neuropod cells respond to
sugar within the small intestine. Further, neuropod cells are essential for driving choices for sucrose over
artificial sweetener. Therefore, it stands to reason that neuropod cells could be involved in long-term food
preferences. However, enteroendocrine cells, a class of cells in the gut epithelium that includes neuropod cells,
are believed to turn over rapidly with some studies suggesting a lifespan as short as three-to-five days.
Therefore, it is unclear if the longevity of neuropod cells supports a role in long-term food preferences.
Preliminary data included in this proposal finds a population of neuropod cells, called long-lived neuropod cells,
that can live up to six months—a quarter of the life of the animal. Further, these preliminary data show that
long-lived neuropods have more connections with sensory neurons than their less mature counterparts.
Because in other sensory systems like olfaction, active receptors survive, and it has been established that
neuropod cells reliably respond to sugar in the small intestine, this proposal hypothesizes that response to
sugar leads to increased connections with neurons that facilitate survival. The first aim of this proposal will test
this hypothesis using a 2D gut organoid model to evaluate the effect of supplemental sugar and the presence
of neurons on neuropod cell activity and survival. The second aim of this proposal will focus on the function of
long-lived neuropods with regards to sugar preferences. Using a combination of targeted ablation and
optogenetic inhibition, this proposal aims to show that long-lived neuropods are necessary for the
establishment and maintenance of long-term sugar preferences. Overall, this proposal will seek to characterize
a long-lived gut-brain pathway and define its role in terms of long-term gustatory behavior. This has significant
implications for obesity, but since chronic gastrointestinal disorders such as the Disorders of Gut-Brain
Interaction (DGBI), which include irritable bowel syndrome and chronic constipation, are also believed to act
via a gut-brain mechanism, defining a functional long-lived gut-brain circuit is essential for the study of these
diseases as well. In addition to making a significant contribution to the study of gut-brain interactions, this
fellowship includes critical technical and knowledge-based training in sensory biology for Dr. Zachary Lorsch.
Combined with training in leadership, mentorship, and communications provided by sponsor Dr. Diego
Bohórquez and co-sponsor Dr. Rodger Liddle, this fellowship will allow Dr. Lorsch to fuse his background in
molecular neuroscience with his clinical training in gastroenterology and become a successful physician-
scientist researcher at the intersection of neuroscience and gastroenterology.

Public health relevance
PROJECT NARRATIVE Early exposure to foods affects long-term food preferences, but the mechanism by which this occurs is unknown. In this project, we explore longevity in a long-lived version of a gut sensory cell, the neuropod cell, and determine whether long-lived neuropod cells drive long-term preferences for sugar intake. This research in significant in that it aims to characterize a long-term gut-to-brain communication pathway that could be essential for understanding unhealthy food choices as well as chronic diseases involving gut-brain communication such as irritable bowel syndrome.